Administration

PROJECT SUMMARY (See Instructions): The Administrative Core (Core A) exists to facilitate and coordinate the components ofthe Program toward fulfilling the Program's mission;the overall objective of the Program is the development of innovative methods of gene therapy for metabolic disorders, and especially the mucopolysaccharidosis (MPS) diseases. The Program is comprised of three research projects and three supportive cores. Core A will provide centralized administrative functions for the Program. To that end, the Administrative Core will implement efficient use of the resources, encourage synergism, organize meetings of Program participants and of the External Advisory Committee. The core will also facilitate maintain and update databases that support Program activities and serve as a central communications hub for the investigators, research staff, and support personnel, as well as provide centralized financial and accounting services support.

Public health relevance
RELEVANCE (See Instructions): Proper administration of a Program this large and productive is crucial to its success.